Problem-Solving Therapy for Cancer Caregivers: A Randomized Clinical Trial in Outpatient Palliative Care

ABSTRACT
In recent decades, the primary setting for oncology treatment has shifted from the hospital inpatient unit to the
outpatient clinic, leaving nearly 4.6 million family caregivers responsible for most of the day-to-day, round-the-
clock cancer care provided in the United States. Cancer caregiving often occurs in a highly stressful emotional
and social context, leaving caregivers vulnerable to significant, potentially long-lasting, adverse effects.
Although palliative care teams are ideally positioned to help family caregivers cope with the numerous
stressors they encounter, there is little evidence on which to base cancer caregiver support in the outpatient
palliative care clinic. To address the pressing need for research on caregiver interventions in this setting, an
interdisciplinary team of investigators will conduct a multisite, randomized trial of problem-solving therapy for
family caregivers of individuals with cancer who are receiving outpatient palliative care. Potential barriers and
facilitators to the adoption of problem-solving therapy in both rural and urban clinics will also be examined,
resulting in a greater understanding of the context in which the therapy will ultimately be delivered if shown to
be effective. The study’s specific aims are as follows: 1) determine the effect of problem-solving therapy on
psychological distress among family caregivers of patients with cancer receiving outpatient palliative care; 2)
measure the effect of problem-solving therapy on positive aspects of caregiving among family caregivers of
patients with cancer receiving outpatient palliative care; and 3) identify potential barriers and facilitators to the
adoption of problem-solving therapy for family caregivers in outpatient palliative oncology. At the conclusion of
the study, investigators will broadly disseminate findings regarding the effectiveness of problem-solving
therapy, and they will be well positioned to promote family caregiver wellbeing through the routine and
sustained delivery of problem-solving therapy in outpatient palliative cancer care.

Public health relevance
PROJECT NARRATIVE Congruent with the National Cancer Institute’s support of patients and families across the cancer trajectory, researchers will test a problem-solving therapy intervention for family caregivers of individuals with cancer who are receiving outpatient palliative care, providing a much-needed evidence base for caregiver support services in this setting. Potential barriers and facilitators to adoption of the intervention in outpatient palliative care clinics will also be examined, resulting in a greater understanding of the context in which the intervention will be delivered if shown to improve caregiver outcomes.